ISLET CELL AUTOANTIBODIES AND NATURAL HISTORY OF INSULIN DEPENDENT DIABETES

The goals are to gain insight into the disease process so as to predict who will develop the disease and when. The objectives and research plan of this proposal is to study the natural history of the pathogenic evens leading to the clinical onset of insulin dependent debetes mellitus (IDDM).